Genetic code expansion to enable the development of short, diverse peptide libraries

Project Summary
Many intracellular cancer targets involve protein-protein interactions that are “undruggable” because the
binding surfaces are too large and featureless to be blocked by a standard rule-of-5 compliant small molecule.
Recently, there have been attempts to catalog molecules that are orally bioavailable but lie beyond the rule of
five (bRo5). Macrocyclic peptides can inhabit this bRo5 space, and a key advantage to using peptides as
bRo5 molecules is that there are many mature techniques for finding peptide binders from vast libraries.
Arguably, the most powerful of these techniques is mRNA display, which allows creation of peptide libraries
containing over 10 trillion variants, 6-7 orders of magnitude larger than a standard peptide library prepared on
beads. The extreme diversity of these libraries has enabled many successes in inhibitor development. Yet
these successes are disconnected from real drug discovery, because the peptides uncovered are much too
large to be bRo5 compliant. Libraries that are short in sequence and bRo5 compliant can be created by mRNA
display, but these libraries lack the diversity needed to uncover potent inhibitors because standard mRNA
display is limited by the genetic code to ~20 variants at each position. Addition of unnatural base pairs (UBP)s
offers great potential to address this problem. In fact, the addition of a single UBP into the genetic code at a
single codon position opens 32 new empty codons. In principle, these codons can be exploited to encode
novel non-canonical amino acids which in turn will dramatically enhance the potential diversity of short
macrocyclic peptide libraries. Still, genetic code expansion on this scale has not before been attempted, and,
therefore, the key goals of this proposal are to prepare, validate, and optimize the mRNAs, tRNAs, and non-
canonical amino acids required to build this system. The validated system will be able to create macrocyclic
peptide libraries that are short, yet contain billions of variants for the discovery of bRo5 compliant inhibitors to
undruggable cancer targets.

Public health relevance
Project Narrative. The proposed research aims to build a new technology that will dramatically enhance the discovery of drugs that bind to and block interacting proteins that are associated with cancer.